STTR Phase II: Advance Early Detection of Lupus Nephritis with ClearGold

Abstract
Systemic lupus erythematosus (SLE) or lupus is an autoimmune disease that affects more than 5 million
people worldwide, including 1.5 million Americans. Nearly 60% of these patients will develop lupus nephritis,
which can cause kidney failure. Thus, its financial burden to individual patient can reach $70,000/year, much
higher than many other diseases because of kidney transplantation. Although early treatment of lupus nephritis
can significantly slow down or even prevent the disease progression to kidney failure, proteinuria, our current
clinical standard for screening lupus patients, is not sensitive and accurate enough for early detection of lupus
nephritis. While new endogenous biomarkers or exogenous markers are being tested in clinical trials for early
diagnosis of lupus nephritis, none of them has outperformed proteinuria in the clinics. As a result, even today,
proteinuria remains the clinical standard and there are strong unmet needs for early detection and accurate
monitoring of kidney damages in the lupus patients. To address this unmet need, ClearNano Inc. is developing
a test agent, named “ClearGold” that can be used as an exogenous urine marker to detect lupus nephritis much
earlier and more accurately than proteinuria. Sponsored by previous STTR Phase I grant, using a renal clearable
gold nanoparticle as a prototype test agent, ClearNano has successfully validated the feasibility of ClearGold in
detection and staging of lupus nephritis in mouse model much earlier and more accurately than proteinuria, and
found it also outperformed other classical endogenous and exogenous markers being evaluated in the clinical
trials for lupus nephritis detection. In this STTR Phase II application, we will identify a lead product, develop
large-scale synthesis under Good Laboratory Practice (GLP) guidelines and conduct in-house toxicity study in
rat model. The success will allow us to prepare a strong package for pre-Investigational New Drug (IND)
meeting with FDA, reduce the risk for comprehensive toxicology studies carried by CRO, and accelerate the
clinical translation of this novel nanotechnology; so that a long-standing unmet need in the early detection of
lupus nephritis can be eventually addressed with our “ClearGold” test agent, which represents a $1.6 Billion
market opportunity.

Public health relevance
Narrative Lupus nephritis influences more than 5 millions patients worldwide and creates huge financial burden for patients with annual medical expense up to $70K/person; however, lack of technologies for early detection of lupus nephritis has been a major challenge for early treatment of lupus nephritis and prevention of the disease progression to kidney failure. ClearNano aims to develop a test agent, named “ClearGold” that can be used as an exogenous urinary marker to detect lupus-induced kidney damages much earlier and more accurately than proteinuria, the clinical standard as well as other classical endogenous and exogenous kidney markers being evaluated in the clinical trials. The feasibility has been successfully validated with a prototype agent in the STTR Phase I studies and we will further advance the clinical translation through the STTR Phase II studies by accomplishing key milestones; so that we can prepare a strong package for a pre-IND meeting with FDA and IND filing.